Skin probiotics to treat Netherton Syndrome

Project Summary
Netherton syndrome (NS) is a severe genetic disorder that affects the skin, hair, and immune system. NS is
caused by mutations associated with the SPINK5 gene which encodes LEKTI (Lympho-epithelial Kazal-type
inhibitor), a serine protease inhibitor. Normally, skin shedding is controlled by an extracellular balance between
serine proteases and serine protease inhibitors, and mutations in LEKTI result in overactivity of serine
proteases. There is not an FDA-approved therapy or consensus treatment of conditions, and symptoms are
mostly managed through antibacterials, emollients and corticosteroids. An enzyme-replacement therapy of
topically applied LEKTI could be an elegant solution, but the short half-life of LEKTI precludes this possibility.
The skin microbiome is home to over 1011 bacteria, and provides an attractive target as a delivery vehicle
through continuous delivery of LEKTI. Through synthetic biology, we will engineer a bacteria to colonize the
skin surface and secrete bioactive LEKTI to restore balance to the skin shedding process. In this Phase I
SBIR, we will establish the safety of our topical application in in vitro models and demonstrate bioactive
secretion of LEKTI fragments. This will provide a strong foundation to transition to Phase 2 where we will
establish safety and efficacy in murine genetic models.

Public health relevance
Project Narrative Netherton syndrome (NS) is a rare hereditary disorder that results in skin, hair, and immune abnormalities and high post-natal mortality. Without an FDA-approved therapy, treatment options are based on only ameliorating the symptoms such as infection, dryness, and itchiness. This project develops an engineered skin probiotic as a platform to treat Netherton Syndrome and provides a platform for the treatment of other skin diseases.